IN VIVO MAGNETIC RESONANCE (MR) STUDIES OF GLUCOSE METABOLISM IN HUMANS

The purpose of this protocol is to develop methods to use magnetic resonance spectroscopy in the study of glucose metabolism in the brains of healthy humans. In this protocol, healthy volunteers re recruited to undergo hyperglycemic clamps while magnetic resonance spectroscopy measurements are being performed to for later determination of intracerebral glucose concentrations.